FUNCTIONAL ANALYSIS OF SLEEP HOMEOSTASIS IN DROSOPHILA

Although the precise function of sleep remains unknown, there is little question that
sleep is required for maintaining optimal performance in a large and diverse number of
biological systems. Indeed, cognitive impairments associated with aging and
neurodegenerative disorders are frequently accompanied by deficits in sleep physiology
and architecture. We have previously shown that enhanced sleep can reverse memory
deficits even in flies with catastrophic lesions to their primary memory center. We have
now mapped a minimal circuitry required by this memory assay. Using genomics and
behavioral genetics we have identified genes that can restore memory when they are
modulated in a single circuit-component in a similar fashion as that produced by sleep.
In this proposal we will determine the molecular pathways that regulate these genes. In
addition, we will use calcium imaging to determine how restoring a single circuit
component modulates the activity of other circuit components to restore memory during
brain damage or the expression of Human Alzheimer's' related genes.

Public health relevance
We propose to determine how sleep can fix broken brains so that we can learn how to harness the power of sleep to better treat degenerative diseases and neurological disorders.